ULTRASTRUCTURE AND FUNCTION OF NERVE AND MUSCLE

One of the objectives of this project is to investigate the ultrastructure of the crustacean stretch receptor organ in relation to its function. We plan to investigate stretch-induced structural changes in the dendrities of the sensory neuron, where the generator potential occurs, by using ultraquick freezing and freeze-substitution methods. In addition, the membrane fine structure of the inhibitory synapses on the receptor neuron will be studied by using the freeze-fracture method. The other objective of this project is to investigate the ultrastructural and electrophysiological properties of newly-formed neuromuscular junctions in tissue culture. Also we will study the development of extrajunctional acetylcholine receptors in cultured muscle cells by using microelectrophysiological and freeze-fracture methods.